One Health Research Training Curriculum for Native Hawaiians and Pacific Students

Abstract
The central mission of MARC at University of Hawaii at Manoa (MARC@UHM) is to provide training in
biosciences research to diverse UHM students who are underrepresented in STEM-related PhD programs.
This two-year training program provides these students with the technical, operational, and professional skills
needed to pursue PhD and MD/PhD programs at research-intensive institutions. This supplement proposes to
complement the MARC@UHM program by introducing students to an interdisciplinary and integrated science
curriculum on One Health, an approach that recognizes the interconnections between human health, animal
health, and environmental science. This administrative supplement proposes to integrate the principles of One
Health into the MARC@UHM research training program and to provide trainees with concrete examples of the
interconnections between human medicine, animal medicine and environmental science. The University of
Hawaii has developed One Health certificate programs for undergraduate and medical students and has made
a commitment to the implementation of One Health to address health challenges in Hawaii and the Pacific
Islands. This proposal describes the development of a five-week One Health course for MARC@UHM
trainees with the following specific aims: (1) To provide undergraduate students with a foundation in the basic
principles of the One Health approach to address global health issues as well as health challenges in Hawaii
and other Pacific Islands, (2) To engage students in active discussion with interdisciplinary faculty of examples
of challenges requiring a One Health approach, (3) To explore the application of process flow diagramming to
address complex health challenges involving multiple sectors/stakeholders, roles, and responsibilities through
use of the One Health Systems Mapping and Analysis Resource Toolkit, OH-SMART, and (4) To provide
students with an opportunity to communicate One Health concepts to their peers and to the public. Course
effectiveness will be determined through an evaluation plan that includes a course evaluation survey
administered to students completing the course and an assessment of survey data by the program evaluator
and program director. Dissemination of the project activities and outcomes will be through presentations to the
Advisory Committee and at the meeting for NIGMS training, workforce development, and diversity programs. If
found to be effective this course will be integrated into the regular MARC@UHM training program. Gaining
awareness of the importance of interdisciplinary research will supplement existing training provided by the
program in specific research areas and will stimulate students to consider professional careers requiring a
skillset that crosses disciplinary boundaries.

Public health relevance
Project Narrative This supplement proposal complements the existing MARC@UHM training program for undergraduate students by integrating the concept of One Health and application of the One Health approach to address complex challenges in human health, animal health, and their shared environment. The program will consist of a five-week course led by an interdisciplinary team of researchers in various areas of One Health and includes an evaluation component that will determine whether this course should be integrated into the 2-year research training curriculum of the MARC@UHM program.